A Randomized Controlled Trial of BETTER, A Transitional Care Intervention, for Diverse Patients with Traumatic Brain Injury and Their Families

ABSTRACT
Black and Latino younger adults (age 18-64) with mild-to-severe traumatic brain injury (TBI) face inequities in
TBI-related consequences, demonstrated by higher incidence and hospitalization rates, and worse cognitive,
physical, behavioral, and emotional impairments <12 months post-discharge compared to Whites. These
impairments affect patients’ abilities to independently manage their health, wellness, and activities of daily living,
resulting in dependence on family, particularly for racial/ethnic minorities. The complexity of needs combined
with the fragmentation of healthcare services creates the perfect storm for low patient quality of life (QOL),
mismanaged symptoms, rehospitalizations, and increased caregiver strain. Lack of insurance or access to care,
as well as language barriers, aggravate these ongoing issues. Despite complex health needs, there are no U.S.
standards for transitional care for patients with TBI. Transitional care is defined as actions in the clinical
encounter designed to ensure the coordination and continuity of healthcare for patients transferring between
different locations or levels of care (e.g., acute hospital care to home). In other patient groups with acute events
(e.g., stroke, myocardial infarction), transitional care interventions have led to improved patient QOL and health
outcomes. Yet, few TBI transitional care interventions exist, and these existing interventions do not equitably
address needs of racial/ethnic minorities. The prevailing racial/ethnic disparities in TBI outcomes and the paucity
of theory-driven, evidence-based TBI transitional care interventions led our team to develop a culturally-tailored
intervention named BETTER (Brain Injury, Education, Training, and Therapy to Enhance Recovery). Based on
the Individual and Family Self-Management Theory (IFSMT), BETTER is a patient- and family-centered,
behavioral intervention for younger adults with TBI discharged home from acute hospital care and families. The
goal is to improve patients’ QOL (change in SF-36 total score, primary outcome) by 16-weeks post-discharge,
as this timeframe includes high rates of unmet patient/family needs and preventable clinical events. Skilled
clinical interventionists follow a manualized intervention protocol to address patient/family needs; establish goals;
coordinate post-hospital care, services, and resources; and provide patient/family education and training on self-
and family-management and coping skills <16 weeks post-discharge. Findings from our NIH R03 pilot study
showed BETTER significantly improved patients’ physical QOL by 31.36 points (p = 0.006) and that the
intervention was feasible and acceptable with younger adults with TBI and families. Thus, the purpose of this
study is to examine the efficacy of BETTER (vs. usual care) among younger adults with TBI of various
races/ethnicities who are discharged home from acute hospital care and families. Findings will guide our team
in designing a future, multi-site trial to disseminate and implement BETTER into clinical practice to ultimately
enhance the standard of care for younger adults with TBI and families. The new knowledge generated will drive
advancements in health equity among younger adults with TBI of various races/ethnicities and families.

Public health relevance
PROJECT NARRATIVE Despite racial/ethnic disparities in outcomes for younger adults with traumatic brain injury (TBI), there are no U.S. standards for TBI transitional care for patients discharged home from acute hospital care. To enhance the standard of care, we will examine the efficacy of our existing intervention named BETTER (Brain Injury, Education, Training, and Therapy to Enhance Recovery), a culturally-tailored, patient- and family-centered TBI transitional care intervention, compared to usual care, among younger adults with TBI and families. The knowledge generated will drive improvements in health equity for younger adults with TBI of various races/ethnicities and families, resulting in improved health of the public.